Intermingling of circulating B cells and cerebral spinal fluid B cells with advancing age

The broad, long term objective of this project is to elucidate the role that the B cell arm of the immune system
plays in the pathophysiology of aging from the stand-point of, and hypothesis that, B cells and the antibodies
they make play a pathogenic role. The specific focus of the present application is to elucidate the
immunoglobulin repertoire of B cells present in human cerebral spinal fluid (CSF) samples in comparison with
B cells circulating in the periphery to determine the extent to which there is B cell intermingling between the
periphery and the central nervous system (CNS) in old age. This work is designed to test a novel and
unexplored mechanism underlying the dyscrasias of aging and associated neurodegeneration.
B cells exist in the CNS of healthy people as evidenced by their presence in cerebral spinal fluid (CSF).
Where do these B cells come from and how do they end up in the CNS? B cells in the periphery circulate
throughout the body but one place they do not enter is the central nervous system (protected by the blood
brain barrier). Or do they? We addressed this issue by analyzing antibodies produced by individual B cells,
because antibody sequence can act as an address or identifier for each B cell. We found that CNS B cells
constitute a population separate and distinct from peripheral B cells in healthy young human volunteers. A
recent study of young mice by another group confirmed that CNS B cells are completely separate and distinct
from peripheral B cells in these animals…BUT, of greater consequence, the same study reported that in old
mice, the antibody repertoires of CNS and peripheral B cells overlapped to a significant extent, indicating
translocation/migration of peripheral B cells to the CNS. It is now imperative to determine whether the same
occurs in old people, as this could constitute a mechanism whereby autoreactive B cells gain access to the
CNS and promote inflammation, which is considered an important factor in cognitive aging and the
pathogenesis of neurodegenerative illness. The unknown degree to which peripheral B cells contribute to the
population of CNS B cells in old people represents a key gap in knowledge whose resolution is likely to have
important implications for concepts regarding normal physiology and disease pathology. We propose to test
the hypothesis that B cells in the CSF are related to peripheral B cells in old people.
We will evaluate the phenotypic nature of CSF vs peripheral blood B cells by immunofluorescent
staining in old and young people. We will evaluate overlap between CSF and peripheral blood B cells by
PCR amplification and then sequence analysis of B cell-expressed antibodies from samples obtained from
the same individuals at the same time. This work will provide completely new information concerning the
hypothesis that B cells move from the periphery to the CNS in old age, and in so doing contribute to age-
associated degeneration and disease initiation and/or exacerbation. If true, a new paradigm will form for
future studies in basic and clinical neuroimmunology.

Public health relevance
Narrative B cells have been thought to be absent from the central nervous system, but recently B cells have been shown to be present in cerebral spinal fluid (that bathes the brain) of normal healthy human volunteers, which could be a problem because although B cell produce protective antibodies they can also generate autoreactive antibodies that have the capacity to damage normal tissues. We have shown that in young people B cells in the central nervous system do not overlap with, or come from, the bloodstream, meaning that B cells in the central nervous system are completely separate and distinct from circulating B cells-- work by another group similarly finds that circulating B cells do not enter the central nervous system in young mice; however, the situation in old mice is completely different in that peripheral B cells are, in fact, found within the central nervous system. We will determine whether migration/translocation of peripheral B cells to the central nervous system occurs in old people because, if so, B cells making autoantibodies that cross over to, and end up in, the central nervous system could participate in the pathogenesis and/or progression of age-associated neurodegenerative diseases that involve inflammation and this new understanding might lead to new approaches for disease prevention or treatment.